NARCH 11 Admin Core

ADMINISTRATIVE CORE PROJECT SUMMARY:
We seek support to continue our NW NARCH program, building upon successful experience with our earlier
rounds of NARCH funding for various research and trainee development projects. We bring many years of
collaborative experiences to the NARCH—including collaborations among Board-based investigators, OHSU
investigators (our primary academic partner), and Portland State University. Our Administrative core will help
facilitate activities among the three partners, and is organized to support the overall success of the Northwest
NARCH. Our NARCH activities are housed within the NW Tribal Epidemiology Center at the Northwest
Portland Area Indian Health Board, and the many years of experience of the EpiCenter will serve the success
of our NARCH program.
Our Administrative Core’s major activities will include:
1. To provide administrative leadership and oversight for the component NARCH 11 projects
described in this application and align activities with existing NARCH training and research
projects;
2. To provide process and outcome evaluations for component projects within our NARCH 11 application;
3. To report NARCH progress to the delegates from the 43 NW tribes, to national NARCH project officers,
to upper level administrators (deans and provosts) at the partner universities, and to Community and
Scientific Advisors;
4. To seek out and disseminate information to collaborators on research and training opportunities for
investigators, students, tribal health workers; and
5. To support investigators’ travel to the annual NARCH director meetings and scientific meetings.
Our administrative core team has worked together for many years on projects that have addressed regional and
national AI/AN health issues, and we look forward to collaborating again on the NW NARCH 11 grant. The
program that we have planned is consistent with the NARCH PAR, as well as the NIH Strategic Plan for
Tribal Health Research FY 2019-2023. We are excited to contribute to the health-related priorities
highlighted in these two documents.